VA Palo Alto Health Services & Life Sciences Summer Research Program: Enhancing the VA Research Pipeline

Background. Increased diversity allows for greater innovation in health systems and life sciences
research. The VA Palo Alto Health Systems & Life Sciences Summer Research Program was designed to
enhance the VA research pipeline by offering a diverse cohort of undergraduate students, including those from
underrepresented groups like Veterans and individuals with disabilities, training in research. Unlike existing
Veterans Health Administration (VHA) internships, this program focuses on students with limited experience,
early in their academic journey (e.g., community college students) with the aim of encouraging trainees to pursue
a research career with VHA by introducing them to research fields that they may not have considered before.
Program Content and Innovation. In recognition of the breadth and scope of VHA research, we
identified two categories of research relevant to VHA—(1) Health Systems (HS) and (2) Life Sciences (LS). The
HS track focuses on research that improves Veteran health by developing, testing, and implementing
interventions that improve the organization, delivery, and effectiveness of health care and related services for
Veterans. The LS track focuses on basic and translational research intended to produce more fundamental
knowledge and therapeutic strategies to treat diseases relevant to Veterans. The internship program will provide
mentorship in research, support academic and career advancement, prepare students for graduate school, and
facilitate peer networking. Taking advantage of the unique resources in the local Silicon Valley region, known for
innovation and entrepreneurship, the program also integrates concepts of innovation into the hands-on research
projects and didactic learning program. The majority of interns' time (70%) will be spent working on a research
project with their primary mentor, guided by an individualized development plan (IDP), which will culminate in a
research presentation at the end of the internship. These hands-on experiences will be supplemented with
didactics focused on the basics of research, track specific fundamental knowledge, and information to foster
career development. Furthermore, through organized and unofficial activities, interns will network with numerous
VHA professionals during the internship program who can serve as role models and provide perspectives on
careers in the VHA.
Evaluation & Impact. Based on evaluations from mentors and interns, the primary benchmarks for
success will be based on: >25% improvement in interns showing increased interest in pursuing employment with
the VA; and 80% of the students completing at least 60% of the IDP elements. The outcomes will be reviewed
by an Advisory Board, consisting of internal and external experts in the field of research and education outreach.
Their feedback will be used to adjust future iterations of the internship. Improving the diversity of the VHA
workforce is vital to ensuring that research will continue to foster scientific innovation, a robust learning
environment, and enhance public trust. This internship program will expose a diverse group of students to career
opportunities available in research thereby supporting a growing pipeline of diverse leaders in VHA and
improving Veterans health and well-being.

Public health relevance
The VA Palo Alto Health Systems & Life Sciences Summer Research Program will recruit undergraduate interns from diverse backgrounds, including those from backgrounds underrepresented in research. The 8-week program will provide interns with hands-on research experiences facilitated by a primary mentor and will culminate in an end of program research presentation. Interns will also complete didactics related to foundational research methods, innovation, track-specific information (e.g., introduction to implementation science, animal models in translational research), and how to flourish in research.. As a result of the program, trainees will build their professional and peer networks while gaining a strong research foundation with which to pursue additional opportunities, thereby widening the pipeline of future leaders in science, research, and healthcare in mission areas important to the Veterans Health Administration.